Regulation and Physiological Roles of Translational Fidelity

PROJECT SUMMARY
The goal of this project is to enhance the diversity of the biomedical research workforce by
training a Ph.D. student from an underrepresented minority group
(African Americans) and facilitate her development towards an independent scientist in the field
of microbiology and pathogen-host interactions. The student will receive rigorous training to
study pathogen-host interactions, protein synthesis, bacterial genetics, and microbial stress
responses. Translational fidelity is critically maintained throughout evolution to ensure accurate
protein synthesis. However, the role of translational fidelity in pathogen-host interactions
remains largely unknown. The proposed training aims at studying how translational fidelity
affects Salmonella-macrophage interactions. During the training, the student will (a) develop
important research skills covering bacterial genetics, single-cell analyses, cell culture, molecular
biology, and biochemistry, (b) enhance her skills of critical reading, thinking, presentation, and
writing, and (c) strengthen her ability of proper experimental design and development of
hypothesis-driven research. In addition, the student will have the opportunities to further career
development by engaging in presenting research at local/national/international meetings,
mentoring students, and taking professional training courses. The outcomes of the proposed
training will help elucidate the role of translational fidelity in pathogen-host interactions using
Salmonella as a model, further the student’s development as an independent microbiologist,
expand the student’s professional network, and promote diversity in the workforce of
microbiology and infectious diseases.

Public health relevance
PROJECT NARRATIVE Salmonella enterica causes over a million illnesses and tens of thousands of hospitalizations annually in the United States, and a much higher burden on global health. The proposed training will help understand how Salmonella interacts with host cells and facilitate future development of treatment to block infection and transmission of this pathogen.